Sleep deficiency and autonomic function in pediatric chronic abdominal pain

PROJECT SUMMARY/ABSTRACT
Childhood chronic abdominal pain is highly prevalent, and associated with significantly poorer physical and
psychosocial functioning, and increased school absenteeism. Moreover, these children are at a greater risk of
becoming adults with chronic abdominal pain, overlapping pain syndromes and psychosocial dysfunction.
Chronic pain has become a public health crisis, with annual costs exceeding $600 billion. At present, the
mechanisms underlying chronic abdominal pain are not well understood, limiting the development of
interventions. There is now compelling evidence that sleep deficiency may be a precursor of pain development.
Additionally, sleep deficiency is associated autonomic dysfunction and affective disorders that are commonly
reported by individuals with chronic abdominal pain, highlighting shared central neurobiological processes.
Understanding the role of sleep deficiency as a potential mechanism of chronic abdominal pain will expand
avenues for treatment. The long term goal of this research program is to develop novel strategies to interrupt
the trajectories of chronic abdominal pain. The objectives of this application are to elucidate the longitudinal
impact of sleep deficiency on the course of abdominal pain in adolescents, and to delineate the roles of
autonomic and psychological function in this relationship. This proposal outlines a well-integrated research and
training plan for mentored, patient oriented career development supported by an interdisciplinary team of
mentors with expertise in adolescent development, psychophysiological research, longitudinal modeling, and
clinical research applications. The central aims are to compare sleep deficiency, pain processing, autonomic
and psychological function in adolescents with chronic abdominal pain compared to healthy adolescents
(Study 1); and to evaluate these longitudinal trajectories and inter-relationships for adolescents with chronic
abdominal pain compared to healthy adolescents over 6 months (Study 2). Assessments will include subjective
evaluation of pain, autonomic and psychological function, in addition to home-based actigraphy monitoring of
sleep patterns that will be paired with laboratory assessment of psychophysical pain tasks and heart rate
variability. Data generated from this research will directly inform a planned R01 proposal to develop tailored
interventions targeting sleep deficiency and autonomic function as modifiable risk factors for treatment.

Public health relevance
PROJECT NARRATIVE Childhood chronic abdominal pain is highly prevalent. At present, due to limited understanding of underlying mechanisms, it remains a medical dilemma. This proposal investigates sleep problems as a precursor of pain, and tests the role of autonomic and psychological factors to guide the development of novel interventions.